The Genetic Control of Social Behavior in the Mouse

DESCRIPTION (provided by applicant): Autism spectrum disorders (ASD) are defined solely in terms of behavior. Their diagnostic symptoms: Impairment in social interaction; in communication; and restricted, repetitive, and stereotyped patterns of behavior; have presented a challenge in terms of the mouse models that facilitate research on the biology of these disorders. This laboratory, with its focus on behavioral analysis, will work with 3 outstanding behavioral geneticists, Drs. Jacki Crawley, Valerie Bolivar, and W. Scott Young, to integrate novel behavioral approaches with the use of candidate genes for involvement in the control of behaviors potentially related to ASD. Our preliminary studies using ethological and experimental approaches to mouse sociality have identified two interactive amicable or eusocial (i.e. not based on aggressive or sexual motivations) behaviors in C57BL/6J mice (huddling and frontal approach), and one mouse communication behavior, scent marking, that may provide parallels to these diagnostic symptoms of ASD. The project will utilize mice with mutations/targeted deletions of each of six genes: Engrailed 2; Reelin; Fragile X; Methyl-CpG-binding protein 2; Oxytocin, and arginine vasopressin 1b receptor, that have previously shown associations with deficient social behaviors, or enhanced representation in ASD or related conditions. The BTBR T+ tf/J mouse strain that has shown striking social deficiencies in previous work, will be used as a [low-social strain]. It will be compared to the C57BL/6J mice that are the background strain for many of these mutations. These mice will be evaluated in three tests: 1) The seminatural Visible Burrow System, in which interactive amicable or eusocial behaviors have been characterized and stereotypicalbehaviors can be detected. 2) Scent marking, using a protocol that measures both social olfactory communication in mice, and, the ability of the subject to form a relatively long-duration social memory differentiating between familiar and an unfamiliar conspecifics. Third, a well-established three-compartment test that measures both sociability to conspecifics vs. nonsocial stimuli, and preference for novel vs familiar conspecifics. These tests will also provide nearly 25 hours of videorecordings of each mouse in seminatural and structured situations, enabling a fine-grained analysis of repetitive or stereotyped behaviors, an additional focus of this laboratory. Mice showing significant changes in these behaviors will be evaluated for neurological/locomotor deficits, to assess specificity of changes and subjected to a breeding algorithm to determine if their behavior changes are due to mutant or ablated genes, or to flanking regions on the chromosome. This program will integrate a much finer and more detailed evaluation of behaviors potentially related to ASD with analysis of the effects of mutations in genes that may be related to these disorders. PUBLIC HEALTH RELEVANCE: Autism spectrum disorder (ASD) is an increasingly common neurodevelopmental disorder defined by interactive social deficits, communication deficits, and the presence of ritualistic, repetitive behaviors. Although considerable information is available on genetic conditions that may be associated with ASD, experimental animal research to characterize and verify these gene-symptom relationships has been hampered by the lack of a broad-based and detailed analysis of relevant behaviors in mice. This proposal begins with broad-based and detailed ethological and experimental analyses of mouse social behavior (preliminary studies), and with this laboratory's history of identifying and evaluating repetitive or stereotyped behaviors in rodents, and proposes to work in collaboration with leading behavior geneticists in analyzing these behaviors in mice with mutations in a number of candidate genes for ASD.

Public health relevance
Project Narrative Autism spectrum disorder (ASD) is an increasingly common neurodevelopmental disorder defined by interactive social deficits, communication deficits, and the presence of ritualistic, repetitive behaviors. Although considerable information is available on genetic conditions that may be associated with ASD, experimental animal research to characterize and verify these gene-symptom relationships has been hampered by the lack of a broad-based and detailed analysis of relevant behaviors in mice. This proposal begins with broad-based and detailed ethological and experimental analyses of mouse social behavior (preliminary studies), and with this laboratory's history of identifying and evaluating repetitive or stereotyped behaviors in rodents, and proposes to work in collaboration with leading behavior geneticists in analyzing these behaviors in mice with mutations in a number of candidate genes for ASD.